Notch Signaling in Alloimmunity

ABSTRACT
Allogeneic T cell responses against foreign host antigens mediate graft-versus-host disease, the most
serious complication of allogeneic hematopoietic cell transplantation (allo-HCT). During the course of this
proposal we defined a critical role for Notch signaling in the regulation of pathogenic alloreactive T cells
that mediate graft-versus-host disease (GVHD) in multiple mouse models of allo-HCT. Notch inhibition in
donor T cells led to long-term protection from GVHD morbidity and mortality. Using monoclonal antibodies,
we identified a critical role for Notch1/2 receptors in T cells and Delta-like1/4 (Dll1/4) Notch ligands in the
host, with dominant effects of Notch1 and Dll4. Dll1/4 blockade with a short course of antibodies emerged
as the most promising strategy to target Notch signaling while avoiding systemic side effects of pan-Notch
inhibition. We recently uncovered several remarkable features of Notch regulation in T cell alloimmunity
that warrant further investigation. First, we identified specialized radioresistant stromal cells lineage-traced
with a Ccl19-Cre transgene as the critical source of Notch ligands in secondary lymphoid organs at the
onset of GVHD. These findings uncover a central role for fibroblastic stromal cell subsets in GVHD. Second,
short-term inhibition of Delta-like Notch ligands within days after allo-HCT was essential to confer long-
term protection from GVHD in multiple mouse models. Within this early time window, Notch induced unique
transcriptional effects during the activation of alloantigen-specific T cells that impacted selected aspects of
their differentiation. Third, we studied Notch ligand inhibition in a non-human primate allo-HCT model that
mimics human transplantation. A single dose of anti-DLL4 antibodies had marked single agent activity to
prevent GVHD, showing highly conserved effects of Notch signaling from mice to non-human primates. In
both models, we observed an increased ratio of regulatory to conventional T cells in the gut and striking
protection from intestinal GVHD, the most dangerous component of acute GVHD. We hypothesize that
alloantigen-specific T cells engage in early interactions with specialized subsets of fibroblastic stromal cells
expressing Delta-like Notch ligands, inducing a Notch-driven pathogenic and gut-homing program in T cells
that promotes GVHD. To explore this hypothesis, we will identify individual subsets of fibroblastic stromal
cells that present Dll1 and/or Dll4 Notch ligands to donor-derived T cells early after allo-HCT, map the
anatomical sites that support Notch activation in alloreactive T cells, and define the impact of immune-
mediate injury on the subsequent integrity of stromal networks in secondary lymphoid organs. In addition,
we will identify mechanisms that blunt the accumulation of Notch-deficient T cells in the gut, thus preventing
intestinal GVHD, and investigate the early transcriptional effects of Notch signaling in alloreactive T cells.
These studies will bring novel insights into the regulation of alloimmunity and might lead to the development
of new approaches to limit damaging consequences of T cell reactivity after allogeneic transplantation.

Public health relevance
PROJECT NARRATIVE We have discovered a critical role for Notch signaling in the regulation of damaging immune responses that mediate graft-versus-host disease, a severe complication of allogeneic bone marrow and hematopoietic cell transplantation. The goal of this research project is to identify the specialized immunological niches that function as the source of Notch ligands after bone marrow transplantation; investigate where precisely transplanted T cells first get exposed to Notch ligands and other critical activation signals; and explore the mechanisms by which short-term Notch inhibition after transplantation can lead to durable protection from graft-versus-host disease. Completion of this project will bring essential new information about Notch signaling in immunobiology and pave the way towards development of therapeutic strategies of Notch inhibition for patients with immune-mediated disorders.